Mechanical regulation of cardiac growth and remodeling by VCAN-GPR126 signaling

The heart develops and functions in the presence of mechanical forces generated by its
contraction. Mechanical forces are believed to direct cardiac growth, as well as pathologic
remodeling of the mature heart in response to mechanical load such as hypertension. However,
the mechanotransducing receptors and signaling pathways that mediate such responses remain
undefined, at there are presently no therapies for acquired heart diseases that directly target
this mechanism. Adhesion G protein-coupled receptors (aGPCRs) are activated by mechanical
displacement of their large, ligand-binding N-termini from the transmembrane receptor body.
The aGPCR GPR126 is expressed in the endocardium and required for embryonic survival. To
identify the endogenous ligand for GPR126 we created a GPR126-Tango allele that reports
aGPCR signaling in vivo. Our preliminary studies reveal that endocardial GPR126 signaling in
the developing heart corresponds closely with the level of versican (VCAN), a proteoglycan that
forms a deformable matrix known as cardiac jelly that separates endocardial and myocardial
cells. VCAN expression is re-activated in the mature heart by mechanical strain, and we also
observe re-activation of GPR126-Tango signaling following aortic constriction or myocardial
infarction. This proposal will test the hypothesis that VCAN-GPR126 signaling is stimulated by
mechanical forces during both cardiac development and postnatal remodeling. Aim 1 will use
newly conditional and mutant Vcan and Gpr126 mouse alleles generated in our laboratory, as
well as traditional biochemical approaches, to test the model that GPR126 is an endothelial cell
VCAN receptor that is activated by mechanical displacement of its N-terminus. Aim 2 will test
whether GPR126 is required during development of the cardiac conduction system, and fully
define the role of GPR126 during pathologic cardiac remodeling in response to pressure
overload in the mature heart. The proposed studies are predicted to define a new molecular
mechanism by which the heart responds to mechanical force, and a potential target for
therapies designed to blunt this response under pathologic conditions.

Public health relevance
Common cardiac diseases such as heart failure and atrial fibrillation arise due to increased mechanical strain felt by the heart, but the molecular mechanisms underlying this process remain poorly understood. This proposal will test whether GPR126 is a receptor that is activated by mechanical force during normal development and pathologic remodeling of the heart. The findings may identify new, heart-intrinsic approaches to prevent the progression of human heart disease.